Artificial Intelligence to Improve Clinical Microscopy for Diagnosis of Infectious Diseases

To develop a user-friendly software interface designed to inform point-of-care diagnostic decision making for infectious diseases.